A national Asian American cohort for assessing multi-level determinants in cancer etiology: the ASPIRE Cohort

Abstract
Asian Americans are the fastest growing and most diverse U.S. racial/ethnic group. They have unique and
disparate patterns of cancer, including being the first U.S. racial/ethnic group for whom cancer is the leading
cause of death. Their incidence of certain cancers far exceeds those of other groups, including lung cancer
among never smoking females, nasopharyngeal carcinoma in Chinese Americans, liver cancer in Southeast
Asian Americans, gastric cancer in Korean and Japanese Americans, and thyroid cancer in Filipino Americans.
Counter to the prevailing view that Asian Americans have high socioeconomic status and favorable health,
certain groups have high rates of poverty, low healthcare access, and low rates of cancer screening. As we
acknowledge the importance of the lived experiences of Asian American populations, including chronic stress
and weathering due to historical trauma and anti-Asian racism, acclimating to and establishing a life in a new
country, and navigating unfamiliar and complex institutions and healthcare systems, we propose a paradigm shift
in studies of cancer risk to include the examination of structural and social determinants of health specific to
Asian American populations. We propose to establish the national ASPIRE– ASian American ProspectIve
REsearch cohort, beginning with 20,000 men and women, ages 40-75 (inclusive of all Asian American ethnic
groups and those who are multiracial/ethnic) via focused community-engaged recruitment in six regions that
comprise more than a third of the Asian American population (California (Bay Area, Los Angeles, Orange
County, Sacramento), New York Metro/North Jersey, and Greater Philadelphia Metro/South Jersey), in addition
to national outreach to other U.S. regions. This population-based cohort will include: 1) multiple Asian American
communities; 2) collection of data on health behavior exposures across the life course; 3) detailed information on
structural, social, and environmental factors; 4) novel assessment of epigenetic age; 5) a precision adaptive
design to develop best practices for community-engaged research in traditionally understudied ethnic groups;
and 6) methodologic research on analytic approaches to assess small populations and intersectionality. This
cohort is supported by a national network of researchers and community partners committed to Asian American
health and well-being. We will use transparent and equitable processes among scientific and community
collaborators to inform research priorities, data collection and sharing, and dissemination of timely, actionable,
and policy-relevant study results. The ASPIRE Cohort will thus be suitable to address multi-level contributors to
the unique cancer burden experienced by Asian American populations. This first phase will address structural
and social determinants of health and their impacts on multiple pathways to cancer initiation that considers 1)
healthcare access and cancer screening, 2) cancer-relevant health behaviors, and 3) social epigenomics of
stress embodiment. The ultimate vision of ASPIRE is to serve as a rich, contemporary epidemiologic resource to
advance our understanding of cancer etiology and achieve health equity in Asian American populations.

Public health relevance
PROJECT NARRATIVE We propose to build the national population-based ASPIRE– ASian American ProspectIve REsearch– Cohort with recruitment of 20,000 males and females, ages 40-75, including focused community-based recruitment from California (San Francisco Bay Area, Sacramento, Los Angeles County, Orange County), New York City/north New Jersey, Philadelphia/south New Jersey (these geographic regions collectively represent over a third of the Asian American population in the United States (US)), but also national outreach to recruit from other US regions. We will apply a transparent and equitable process to inform research priorities and data collection, and disseminate timely, actionable, and policy-relevant study data utilizing interactive data visualization methodologies. In building the first national cancer epidemiologic cohort inclusive of all Asian American populations, ASPIRE will address the research priorities of small populations, intersectionality, and the role of structural and social determinants of health in pathways to cancer risk, including social epigenomics of stress embodiment, health behaviors, and healthcare access.